Engineered exosome mimetics as targeted biological nanomedicines for pancreatic cancer

Project Summary/Abstract
Pancreatic cancer (PC) is one of the most lethal forms of cancer in the United States (5-year survival rate
below 10%). PC patients are usually diagnosed with a non-resectable disease (80-85%) and have a dismal
prognosis with a survival period of only 3-6 months after the diagnosis. Nucleoside analogs (e.g., gemcitabine
and fluorouracil) and platinum-based antineoplastics (e.g., oxaliplatin) are commonly used as chemotherapy
for PC. When administered as free drugs, gemcitabine (Gem), fluorouracil (5-FU) and oxaliplatin (Oxa) display
significant off-target toxicity causing life-threatening adverse effects in many patients. There is an urgent need
to develop new therapeutic strategies consisting of delivery vehicles able to target PC cells, limit Gem, 5-FU
and Oxa off-target toxicity and improve the overall anticancer response.
We have recently patented a platform that uses an unbiased and quantitative screening algorithm for the
discovery and validation of cancer-specific surface antigens. Our recently published results show that
Intercellular Adhesion Molecule 1 (ICAM1), a transmembrane glycoprotein of the immunoglobulin superfamily,
is aberrantly overexpressed in PC and can serve as a PC-specific target. Our results suggest that developing
a novel ICAM1-based precision nanomedicine can be successfully utilized to treat PC patients.
We have recently developed a magnetic extrusion technique to synthesize endosome-derived vesicles
called exosome mimetics (EMs) in a highly efficient and reproducible manner. Our EMs share the same
biological origin, morphology, nanosize and composition with exosomes, a class of natural cell-secreted
extracellular vesicles. Our EM synthesis outperforms conventionally used exosome isolation and loading
protocols in terms of particle yield, batch-to-batch consistency, reproducibility and loading efficiency.
In this proposal,we leverage our expertise in cancer-specific antigen discovery and validation, bio-
nanomaterial engineering, and exosome biology to test the novel hypothesis that EMs expressing ICAM1
nanobody and loaded with Gem, 5-FU and Oxa can be used as a novel delivery vehicle for PC therapy. We
will synthesize EMs engineered with ICAM1 nanobodies that recognize and kill ICAM1-expressing PC cells
and load them with Gem, 5-FU and Oxa. ICAM1-EM will exhibit increased tumor specificity and reduce Gem,
5FU and Oxa off-target delivery and toxicity. These innovative studies have the potential to lead to the
development of novel EM-based therapies that can improve the efficacy of current cancer drug delivery.
With key experimental tools, in vivo models and extensive experience in place, we will address the
following Specific Aims:
1. To engineer ICAM1-targeted exosome mimetics (ICAM1-EMs) using magnetic extrusion method
2. To determine the efficacy of loaded ICAM1-Chemo-EMs in inhibiting PC growth and progression
3. To determine the pharmacokinetics (PK) and biodistribution of loaded ICAM1-Chemo-EMs

Public health relevance
Project Narrative Pancreatic cancer (PC) is one of the most lethal forms of cancer in the United States (5-year survival rate below 10%) and is often treated with adjuvant chemotherapeutics (e.g., gemcitabine, 5-FU and oxaliplatin) known for their high off-target delivery and systemic toxicity. There is an urgent need to develop new therapeutic strategies consisting of delivery vehicles able to actively target PC cells, limit chemotherapy off-target toxicity and improve the overall anticancer response. To address this unmet medical need, we will leverage our experience in cancer-specific antigen discovery and validation, bio-nanomaterial engineering, and exosome biology to test the novel hypothesis that EMs engineered with a nanobody against ICAM1, an overexpressed PC surface protein, and loaded with gemcitabine, 5-FU and oxaliplatin can be used as a novel biological nanomedicine for precision PC therapy.